Structure and Functionof Nanog in Stem Cell Pluripotency

Project Summary
NANOG Structure and Function in Stem Cell Pluripotency
NANOG directs access to stem cell pluripotency. There are considerable gaps in our
molecular understanding of how NANOG coordinates this process. This is also compounded by
the fact that NANOG (in particular, human NANOG) has been a challenging system to work
with. The investigators have successfully applied innovative fluorescence techniques to
characterize NANOG’s key structure and functional properties. NANOG is an intrinsically
disordered protein (IDP), with a prion-like domain critical for NANOG self-assembly and for
establishing contacts in pluripotency specific regions. NANOG is a ‘molecular hub’, reported to
interact with >100 transcription factors (TFs) and other proteins to form cooperative hub
condensates and coordinate activation of pluripotency genes and repression of differentiation
genes. The investigators will investigate and deconvolute how NANOG dose-sensitivity play a
role in chromatin looping and recruitment of TFs, co-activators, and epigenetic regulators. They
will use an intensive holistic combination of standard and innovative structural, molecular,
genomic and cell biology approaches. The first aim will elucidate NANOG’s dose-sensitivity
mechanism in establishing pluripotency by assessing chromatin reorganization and recruitment
of cofactors using Hi-C 3.0 and single molecule fluorescence techniques. The second aim will
probe the molecular elements (i.e., OCT4-SOX2-NANOG triad cooperativity and KLF4
biomolecular condensation) involved in activating NANOG expression. In addition, the aim will
investigate the molecular basis for NANOG autorepression. The last aim will focus on inhibition
of NANOG stabilization and oligomerization with dominant negative NANOG-based peptides.
These studies will provide unprecedented insights into how NANOG orchestrates establishment
of stem cell pluripotency and reversal of developmental aging.

Public health relevance
Project Narrative NANOG directs access to stem cell pluripotency. NANOG coordinates interactions with and between key players Oct4, Sox2 and hundreds of other proteins to activate pluripotency genes and repress differentiation genes. The project will probe the fundamental molecular mechanisms of human NANOG structure and function in stem cell pluripotency.